Protein phosphatase1 regulates normal automaticity of heart pacemaker node cells

Basal phosphorylation of sarcoplasmic reticulum (SR) Ca2+ cycling proteins of sinoatrial node cells (SANC) is higher than in left ventricular myocytes (LVC) and is crucial for SANC basal normal automaticity. We hypothesized that the activity of Ser/Thr phosphoprotein phosphatases (PP) PP1 and PP2A or endogenous phosphatase inhibitors limits the basal action potential (AP) firing rate. SANC transcript abundance (RT-qPCR) and protein expression (western blot) for PP1 equaled to these of PP2A. Inhibitor-1 (I-1), and Dopamine- and cAMP-regulated phosphoprotein (DARPP-32) RNA expression and protein levels in SANC were similar and exceeded those of kinase Cenhanced
PP1 inhibitor (KEPI). Inhibition of both PP1 and PP2A activities by Calyculin A (CyA) in intact freshly isolated SANC significantly increased phospholamban (PLB) phosphorylation (by 2-3-fold) at both CaMKII-dependent Thr17 and PKA-dependent Ser16 sites and increased RyR phosphorylation at Ser2809 site. In single rabbit SANC, CyA (100 nmol/L) decreased the spontaneous SANC cycle
length and increased the average spontaneous SANC firing rate (perforated patch-clamp technique) by 30%. CyA substantially increased diastolic local Ca2+ release (LCR) number and size (confocal line-scan imaging) and reduced the LCR period (time from the action potential induced
Ca2+ transient to subsequent LCR). The CyA-induced increase in LCR parameters was accompanied by an increase in RyR phosphorylation at Ser2809 site, concurrent augmentation of L-type Ca2+ current amplitude and elevation of sarcoplasmic reticulum Ca2+ load. The selective PP2A inhibitor okadaic acid (100 nmol/L) had no significant effect on SANC spontaneous AP firing, LCR parameters or PLB phosphorylation. In permeabilized SANC CyA markedly increased LCR number and size and purified PPI suppressed LCRs, while neither okadaic acid nor purified PP2A affected LCR characteristics. A numerical model, fine-tuned by experimentally observed changes in ICaL, PLB phosphorylation and changes in SR Ca2+ pumping produced by PP inhibition in SANC quantitatively predicted changes in SANC AP firing rate in response to PP inhibition. Thus, basal PP activity in SANC is regulated by PP1 which modulates the basal spontaneous firing rate of SANC via suppression of SR Ca2+ cycling protein phosphorylation, SR-generated LCRs and L-type Ca2+
current.
We showed that rabbit SANC express both PP1, PP2A, and endogenous PP inhibitors I-1 (PPI-1), dopamine and cyclic adenosine 3',5'-monophosphate (cAMP)-regulated phosphoprotein (DARPP-32), kinase C-enhanced PP1 inhibitor (KEPI). Application of Calyculin A, (CyA), a PPs inhibitor, to intact, freshly isolated single SANC: (1) significantly increased phospholamban (PLB) phosphorylation (by 2-3-fold) at both CaMKII-dependent Thr17 and PKA-dependent Ser16 sites, in a time and concentration dependent manner; (2) increased ryanodine receptor (RyR) phosphorylation at the Ser2809 site; (3) substantially increased sarcoplasmic reticulum (SR) Ca2+ load; (4) augmented L-type Ca2+ current amplitude; (5) augmented LCR's characteristics and decreased LCR period in intact and permeabilized SANC, and (6) increased the spontaneous basal AP firing rate. In contrast, the selective PP2A inhibitor okadaic acid (100 nmol/L) had no significant effect on spontaneous AP firing, LCR parameters, or PLB phosphorylation. Application of purified PP1 to permeabilized SANC suppressed LCR, whereas purified PP2A had no effect on LCR characteristics. Our numerical model simulations demonstrated that PP inhibition increases AP firing rate via a coupled-clock mechanism, including respective increases in the SR Ca2+ pumping rate, L-type Ca2+ current, and Na+/Ca2+-exchanger current. Thus, PP1 and its endogenous inhibitors modulate the basal spontaneous firing rate of cardiac pacemaker cells by suppressing SR Ca2+ cycling protein phosphorylation, the SR Ca2+ load and LCRs, and L-type Ca2+ current.